Host blood biomarkers for the diagnosis prognosis and treatment response of childhood TB

Project Summary
Childhood tuberculosis (TB) has greater risk of morbidity and mortality than adult disease, yet
diagnostic and prognostic tests discovered in adults are less accurate in children. There is a critical
need for more sensitive diagnostic tests for childhood TB that do not need respiratory sample
collection; for prognostic tests that are more specific in Bacille Calmette Guerin (BCG)-vaccinated
children; and for improved tools to monitor treatment. Two novel approaches, host blood RNA
signatures and the T cell Antigen-Specific Activation assay, target complementary aspects of the
immune response and offer promise as diagnostic, prognostic and treatment-response biomarkers of
childhood TB. A prognostic RNA signature of TB risk that also shows excellent diagnostic sensitivity
and specificity for active TB, and response to treatment that mirrors disease progression, has been
discovered in adults. Validation by qRT-PCR has been achieved; parsimonious 11-gene and 6-gene
versions have been developed with identical performance; and the signature shows promising
diagnostic sensitivity and specificity when applied to published pediatric microarray data. A host blood
biomarker that measures activation of M.tb-specific T cells also yields excellent diagnostic
performance. We validated and translated this T cell biomarker to a simplified whole blood assay
suitable for pediatric use on basic flow cytometers widely available to HIV screening programs. We will
evaluate performance of these two biomarkers for diagnosis and prognosis of pediatric TB disease and
explore response to treatment. We will enroll a cohort of children with household exposure to an adult
TB patient; evaluate them for TB disease by standardized investigation algorithm using a rigorous case
definition; and collect blood for biomarker assays at baseline. Children without prevalent TB disease will
be referred for preventive therapy and thereafter followed for incident TB disease for up to 3 years.
Children diagnosed with TB disease will have blood sampled during curative treatment. We will
evaluate diagnostic performance of these host blood biomarkers compared with Xpert MTB/RIF Ultra
and prognostic performance compared with interferon-gamma release assay (IGRA); discover whether
innate immune genetic variants are associated with biomarker expression; and project public health
impact and cost-effectiveness of biomarker-targeted screening strategies for pediatric TB. A host blood
biomarker that displays a characteristic response through the spectrum of pathogenesis of pediatric TB,
increasing from M.tuberculosis infection through progression to disease and resolving during treatment,
would be a major advance towards better diagnostic, prognostic and treatment monitoring tools for
childhood TB.

Public health relevance
Project Narrative The root cause of systemic failure to identify and treat childhood TB worldwide is the challenge of accurate diagnosis. Two novel biomarker approaches, based on host blood RNA signatures and a simplified T cell Antigen-Specific Activation assay that target complementary aspects of the host immune response, have been discovered and validated in adults and offer promise as biomarkers of childhood TB. We will evaluate diagnostic and prognostic performance of these biomarkers for pediatric TB disease, to inform feasibility and potential impact of biomarker-targeted TB screening strategies for children.